Glutamine Metabolism in Alveolar Macrophages following Influenza A Infection

Project Summary/Abstract
The proposal outlines a research and training plan for Obada Shamaa, MD, PhD, to perform postdoctoral work
in the laboratory of Gokhan Mutlu, MD, for two years. The ultimate goal of this research project is to provide
novel insights into the how glutamine metabolism plays a role in Influenza A-induced Acute Respiratory Distress
Syndrome (IAV-induced ARDS), a disease associated with significant mortality and limited therapeutic options.
This work will be the foundation for becoming a K-level grant. During this mentored period, Dr. Shamaa will gain
expertise in metabolism and techniques to study bioenergetics, redox states, and metabolomics as well as
enhance his previous cellular and molecular biology skills. In addition to mentoring by Dr. Mutlu and a
multidisciplinary Research Monitoring Committee (RMC), Dr. Shamaa will supplement his training with
educational opportunities provided at the University of Chicago. The overall research goal is to identify how
glutamine metabolism is involved in influenza A replication and alveolar macrophage effector function. Metabolic
adaptations to support immune cell function, as well as by influenza A virus (IAV) to support viral replication.
While it is thought that macrophages increase aerobic glycolysis metabolism to support a pro-inflammatory
macrophage response, recent work by the Mutlu lab showed that tissue-resident alveolar macrophages (TR-
AMs) rely solely on mitochondrial respiration to support their effector function. Dr. Shamaa now has confirmatory
data that TR-AMs increase expression of glutaminolysis enzymes in response to IAV infection. Additionally, he
has shown that IAV replication and pro-inflammatory cytokine release is reduced in TR-AMs in the absence of
exogenous glutamine. These data indicate that active regulation of glutamine is critical for IAV replication and
TR-AMs’ effector function. Aim 1 will evaluate the role of glutamine metabolism in IAV viral replication and TR-
AM effector response. Aim 2 will focus on the metabolic changes in TR-AMs infected with IAV following targeting
of glutamine metabolism. The proposed work will require training in bioenergetics and liquid chromatography-
mass spectrometry (LC-MS) and Dr. Shamaa will obtain training in both techniques during this fellowship. This
work seeks to understand how glutamine is utilized in alveolar macrophages following IAV infection as there is
a significant need to identify novel targets for therapeutic interventions for IAV-induced ARDS.

Public health relevance
Project Narrative Influenza A-induced Acute Respiratory Distress Syndrome (IAV-induced ARDS) is associated with 45% mortality and current treatment is supportive. Glutamine metabolism plays a key role in immune function and viral replication but is understudied in IAV-induced ARDS. This project will target the glutamine pathway to identify key sites of metabolic regulation in alveolar macrophage effector function and viral replication, which will serve as the basis for my transition to become an independent investigator.